NICHD CONTRACT TO PROVIDE MAINTENANCE AND ENHANCEMENT OF 2 SYSTEMS OF RECORD- DOWN SYNDROME CONNECT AND PREGSOURCE ONLINE REGISTRIESMAINTENANCE OF RDPR AND CREA

NICHD Base award for Down Syndrome Connect and PregSource online registried for ops & maintenance, and customization and enhancement and new registry development.